Molecular mechanism of juvenile hormone action in mosquito reproduction

Project Summary
Mosquitoes are responsible for the transmission of many infectious diseases such as malaria, dengue
fever, and Zika virus. Vector control using insecticides is currently the primary means of preventing the
transmission of these diseases. In light of the rapid spread of insecticide resistance in mosquito populations, it
is imperative to add new insecticides with different modes of action to the arsenal of mosquito control agents.
The juvenile hormone (JH) signaling pathway is an attractive target for the control of mosquito vectors. JH is a
key regulator of mosquito development and reproduction. Exposure of adult mosquitoes to pyriproxyfen, a
synthetic JH mimic, has shown promise to effectively sterilize female mosquitoes. Our goal of this project is to
elucidate the molecular pathways utilized by JH and its mimics to modulate mosquito fecundity.
Mosquito egg development is mainly governed by JH and 20-hydroxyecdysone (20E). In the last funding
cycle, we demonstrated that the Methoprene-tolerant (MET) protein is an intracellular receptor of JH. Both
natural JH and pyriproxyfen binds to Aedes aegypti MET with high affinity. Upon binding of JH, MET forms a
dimer with Taiman, a transcriptional factor that is involved in both JH and 20E responses. The MET-Taiman
complex directly regulates the expression of JH-controlled genes. Besides the genomic action, we also
reported a rapid JH signaling that is initiated from the plasma membrane. The non-genomic action, which relies
on receptor tyrosine kinases (RTK), modulates the DNA-binding of the MET-Taiman complex and regulates the
alternative splicing of the taiman gene. While the membrane-initiated JH signaling plays critically important
roles in mosquito reproduction, the membrane JH receptor and the specific RTK have not yet been identified in
mosquitoes. Our recent study demonstrates that a small portion of MET is associated with the plasma
membrane in mosquito cells. Furthermore, depletion of MET eradicates the JH-activated increase in
intracellular Ca2+, which is part of extranuclear JH signaling. Thus, our results suggest that the membrane-
associated MET acts as a membrane JH receptor to mediate the non-genomic action of JH.
In this proposed study, we will test the hypothesis that the JH action in mosquitoes is mediated by both
membrane-bound and nuclear MET proteins, and that pyriproxyfen uses this JH signaling pathway to inhibit
20E-regulated gene expression. In Aim 1, we will define the roles of membrane MET in the membrane binding
of JH and the membrane-initiated JH signaling. In Aim 2, we will investigate how membrane MET mediates the
nongenomic action of JH in mosquitoes. In Aim 3, we will elucidate how pyriproxyfen utilizes the JH signaling
pathway to suppress the vitellogenic 20E response. This study will add a new dimension to our understanding
of the JH signaling pathway that is required for mosquito reproduction. It may also reveal new targets in the JH
signaling pathway that can be exploited for pesticide development.

Public health relevance
Project Narrative Juvenile hormone plays a critical role in mosquito egg maturation; its synthetic mimics have shown promise to effectively sterilize adult female mosquitoes. The goal of this project is to elucidate the molecular actions of juvenile hormone and its mimics in mosquitoes and to identify new potential target sites in the juvenile hormone signaling pathway for pesticide development.